Project 1: Fibrolamellar HCC

PROJECT 1 – PROJECT SUMMARY
Fibrolamellar hepatocellular carcinoma (FLHCC) is an often-lethal disease affecting primarily children and
young adults. The poor prognosis is exacerbated by the lack of both existing diagnostic tests and systemic
therapy. We have recently demonstrated that there is a single, consistent deletion in one copy of chromosome
19 in FLHCC patients that results in a chimeric gene. This chimera encodes a fusion protein, a constitutively
active catalytic subunit of protein kinase A. This project has two aims: (1) develop the first diagnostic tests for
this cancer and (2) develop the first blockers for the driver for this cancer.

Public health relevance
PROJECT 1 – PROJECT NARRATIVE Our ability to understand human cancers has been revolutionized the past two decades by the sequencing of the human genome and the ability to introduce altered genes into cells. This project builds upon this by using the study of a pediatric cancer to drive the study of critical genes in human hepatic cells. The project will develop the first diagnostic tests and therapeutic treatments for fibrolamellar hepatocellular carcinoma.